Combined ATR and P13k inhibition in uterine cancer

Project Summary
Replication stress (RS) is defined as the slowing or stalling of the replication fork progression during DNA
synthesis and is widely recognized as a significant cause of genomic instability and a critical feature of cancer
cells. The response to RS is facilitated by ATR kinase which induces a cascade of molecular events to facilitate
cell cycle arrest, stabilization of the replication forks and DNA repair. Inhibition of ATR may be an effective
strategy against tumors with high degree of RS. However, thus far, clinical evaluation of ATR inhibitors (ATRi)
has demonstrated limited efficacy as monotherapy outside the setting of BRCA deficient and ATM deficient
tumors. Using two high-throughput approaches, i.e., PRISM screening of ~800 genomically characterized
human cancer cell-line models and genome-wide CRISPR-based functional screen of ATRi elimusertib, we
found that inhibition of the PI3K pathway may synergize with ATRi. Preliminarily, we have also demonstrated
synergism between PI3K inhibitor copanlisib and ATRi elimusertib in vitro and in vivo. Clinically, this synergism
is particularly relevant to uterine cancer (UC) because of the prevalence of genomic alterations associated with
high RS in uterine serous tumors (e.g. CCNE1 amplification, MYC amplification, FBXW7 mutations) and because
UC (predominantly those with endometrioid or clear cell histology) frequently harbor ARID1A mutations which
have been shown to be associated with cell cycle progression defects in both S and G2/M phases of the cell
cycle leading to increased RS and sensitivity to ATR inhibition. Additionally, although all histologic subtypes of
UC are characterized by PI3K pathway alterations, response to PI3K inhibition as monotherapy has been
disappointingly low and no PI3K inhibitor is currently approved in UC. For all these reasons, we hypothesize that
combined ATR and PI3K pathway inhibition may be an effective therapeutic strategy to capitalize on concomitant
PI3K pathway alterations and high degree of RS in uterine serous and ARID1A-mutated uterine tumors. In Aim
1, we will perform in vitro studies of targeted inhibition of ATR alone and in combination with PI3K inhibition
across a collection of established patient-derived organoids with various genomic backgrounds to assess for
synergism and elucidate its underlying mechanisms. In Aim 2, we will evaluate in vivo synergism between ATRi
elimusertib and PI3Ki copanlisib in PDX and GEMM models of UC and will explore whether this correlates with
IHC assays of replication stress. Finally, in Aim 3, we will conduct a Phase 1b dose escalation trial of PI3K
inhibitor copanlisib and ATR inhibitor elimusertib in UC with two dose expansion cohorts in uterine serous (cohort
A) and ARID1A mutated uterine tumors (cohort B). It is our expectation that the research proposed herein, if
successful, will provide patients with recurrent UC with a new therapeutic option that is applicable across different
histologic subtypes of UC for which no specific therapies exist. Furthermore, if successful, the therapeutic
strategy of exploiting RS and PI3K pathway alterations using combined ATR/PI3K blockade would be readily
applicable to alternative tumor types such as breast, ovarian and prostate cancers as well as cancers with
ARID1A deficiency whose therapy remains a significant unmet medical need.

Public health relevance
Project Narrative Genomic alterations associated with high replication stress (RS) and concomitant PI3K pathway alterations are prevalent in uterine serous and ARID1A-mutated uterine cancers (UC). Based on preliminary data supporting synergistic antitumor activity of combined ATR and PI3K inhibition, this proposal aims to investigate the therapeutic potential and biologic activity of this novel therapeutic strategy in UC, whose incidence and death rates are both significantly increasing in the United States.